TASK D16: MAINTENANCE, DEVELOPMENT AND PRODUCTION OF SCHISTOSOMIASIS PARASITES, REAGENTS AND ASSAYS

This contract provides for the development and standardization of nontraditional animal models for infectious diseases.